Multimodal intraoral camera

ABSTRACT
The WHO Global Oral Health Status Report (2022) estimated that oral diseases affect close to $3.5 billion
people worldwide. Dental caries and cracks are two common dental diseases. Globally, an estimated $2 billion
people suffer from caries of permanent teeth and $514 million children suffer from caries of primary
teeth. Cracked tooth is a common dental hard tissue disease and is the third major cause of tooth loss after
caries and periodontal disease. While there are some adjuncts based on autofluorescence and
transillumination for detecting caries and crack, none of them can provide quantitative and internal tooth
structural information for accurate diagnosis and monitoring treatment progress.
To address the need of a quantitative device for earlier detection and more accurate diagnosis of caries
and crack, Light Research Inc (LRI) proposes to optimize and commercialize a compact multimodal intraoral
camera which uniquely integrates polarized white light imaging (pWLI), autofluorescence imaging (AFI), optical
coherence tomography (OCT) imaging, and novel NIR transillumination imaging (NIR-TI) modalities. Four
imaging modalities with distinct and complementary contrast mechanisms will improve the sensitivity and
specificity in detecting caries and crack significantly.
The novel system design facilitates the compact integration of four different imaging modalities and
enables the seamless transition between imaging modalities. The proposed camera is clinically innovative in
that it will screen the tooth in wide field of view (FOV) imaging modes (pWLI, AFI, and/or NIR-TI) to detect and
segment suspicious region, and then guide OCT scan to obtain internal tooth structural information of the
suspicious region for accurate diagnosis. Earlier caries and crack detection will enable the dental practitioner to
initiate early prophylactic treatment, the internal tooth structural information from OCT image and the registered
wide-FOV pWLI and AFI images will facilitate the monitoring of treatment progress.
To achieve the project goal, LRI has assembled a multidisciplinary team with expertise in developing (Dr.
Wilder-Smith) and validating (Dr. Amaechi) optical technologies for oral diseases including caries and crack,
developing commercial dental products (Dr. Liang), and developing advanced image processing (Dr. Song).
The project team members have collaboratively or independently investigated different imaging modalities for
caries and crack detection, as well as for oral cancer detection and diagnosis. In this project, the team will first
optimize and prototype two compact multimodal intraoral cameras and develop deep learning-based image
segmentation algorithms (Aim 1), optimize system settings and evaluate the proposed multimodal intraoral
camera (Aim 2), and then conduct a pilot clinical study to evaluate performance of the multimodal intraoral
camera in detecting caries and cracks in human subjects (Aim 3).

Public health relevance
Project Narrative Light Research Inc will develop a compact multimodal intraoral camera with four distinct and complementary imaging modalities for detecting and diagnosis of caries and crack. The novel and unique intraoral camera will enable earlier detection, more accurate diagnosis, earlier application of preventive modalities of treatment, and an overall improvement in the oral health of the public.